ORS Musculoskeletal Biology Workshop at Sun Valley

Description This application requests support for the 47th annual meeting of the ORS Musculoskeletal Biology Workshop at Sun Valley, held in Sun Valley, Idaho, August 6-9, 2017. The Workshop emphasizes active participation of junior faculty and students; promotes interdisciplinary communication; and is unusual in that discussion time equals or exceeds time allotted for formal presentation. The goals of the Workshop are to (1) work toward a multidisciplinary basic and clinical synthesis of molecular, tissue and biomechanical processes in bone that help us to understand the pathogenesis of bone disease as well as its prevention and treatment; (2) apply basic science concepts to clinical problems; develop a dialogue between basic and clinical investigators that leads to interdisciplinary collaboration; (3) identify significant problems in musculoskeletal disease, and identify experimental approaches that provide solutions to them and (4) provide a forum for student training and the opportunity in a small group setting for junior scientists to talk with more senior scientists. A partnership between the Workshop and the Orthopaedic Research Society (ORS) provides maximum visibility through broadcast emails and links on the ORS website. This year we continue our newly-instituted focus on problem solving, with the theme for the Workshop being “Modern Methodologies and Novel Therapies.” Four sessions address relevant and significant current problems, including progress in next- generation musculoskeletal therapies, imaging of musculoskeletal tissues, limitations/solutions for engineered animal models of musculoskeletal disease, and finite element applications to clinical and basic science research. In addition, we have selected a problem in endocrinology (Fibrous Dysplasia) and one in orthopaedics (Degenerative Disk Disease). Many opportunities are provided for junior investigators to interact with more senior investigators. A Career Development Workshop specifically geared toward young investigators will be held during one afternoon. Nine ASBMR/Harold M. Frost Young Investigator Awardees will present their work from the podium. Ten Alice Jee Young Investigator Awardees, and up to five additional Jee Award for under-represented minorities at any career stage, will be presented. The Sunday evening session will be devoted entirely to poster presentations, with some short poster presentations from the podium. The Plenary Lecture and RIB Award are scheduled for Sunday morning. All abstracts are posted for public viewing on the ORS website prior to the Workshop. Performance Site Sun Valley, Idaho Key Personnel Name Organization Burr, David B. Indiana University Robling, Alexander G. Indiana University Bellido, Teresita Indiana University Role on Project Workshop Director, Co-I Workshop Associate Director, PI Workshop Associate Director, Co-I

Public health relevance
Public Health Relevance Statement This Workshop is relevant to public health concerns because it brings a multi-disciplinary group of senior and junior scientists together to discuss recent advances in musculoskeletal biology related to bone disease. The Workshop will tackle next-generation musculoskeletal therapies, imaging of musculoskeletal tissues, limitations/solutions for engineered animal models of musculoskeletal disease, and finite element applications to clinical and basic science research. In addition, we will address an important problem in endocrinology (Fibrous Dysplasia) and orthopaedics (Degenerative Disk Disease), and the workshop provides vertically-oriented information, from basic science to clinical pathology, to practitioners and scientists who may not be completely familiar with all aspects of these diseases of public health concern.